Uncovering the roles of oxysterols in neuropathic pain

Chronic neuropathic pain afflicts 15-20 million people in the U.S.1 Defining the molecular mechanisms involved
is key to developing novel non-opioid analgesics.2 We recently discovered that the Gαi protein-coupled receptor
(GPCR) Gpr183 transcript increases in glial cells of the dorsal horn of the spinal cord (DH-SC) following nerve
injury and contributes to ensuing neuropathic pain.3 The primary endogenous ligand for GPR183 is the potent
signaling oxysterol 7α,25-dihydroxycholesterol (7α,25-OHC).4-6 However, little is known about the roles of 7α,25-
OHC/GPR183 in pain beyond our recent publication.3 Moreover, commercial GPR183 antagonists are very
limited and have chemical properties that raise questions about their in vivo utility.3,7 To address this, we initiated
an in silico drug discovery approach that screened 5.5 million commercial compounds with similarities to a
GPR183 pharmacophore model, then docked and ranked the highest similar docking scores.3 The top 16
compounds were tested in calcium mobilization (FLIPR) assays to identify several small-molecule selective
GPR183 antagonists with IC50 values in the nM range, exemplified by SAE-14.3 SAE-14 was counter-screened
against the GPCRome at NIMH PDSP8 with no significant activity for over 300 receptors. Systemic SAE-14
administration reversed mechano-and cold allodynia (behavioral hypersensitivities) induced by nerve injury in
male and female rodents with no observable side effects or engaging the endogenous opioid system.3 These
effects were mimicked by intrathecal (i.th.) injection of SAE-14, identifying the spinal cord as a potential site of
GPR183 antagonist action.3 Moreover, pain behavioral phenotypes were recapitulated by i.th. injection of 7α,25-
OHC or a fluorinated analog that activated Gαi/o-linked (pertussis toxin), GPR183-dependent mitogen-activated
protein kinase (MAPK) signaling (preliminary data). MAPK signaling in the DH-SC is crucial in regulating
neuroinflammatory/pro-nociceptive genes and maintaining persistent pain sensitization.9,10 GPR183-dependent
MAPK signaling was supported by unbiased transcriptomic analysis of the DH-SC from SAE-14-treated rats with
neuropathic pain (preliminary data). SAE-14 lacks sufficient metabolic stability and solubility/absorption
(preliminary data) and structure-activity relationship studies on SAE-14 are necessary for optimization and
discovery of druggable GPR183 antagonists. Based on our published work3 and preliminary data, we
hypothesize that 7α,25-OHC/GPR183 signaling in the DH-SC contributes to the development and maintenance
of neuropathic pain states. Proposed studies in Aim 1 will investigate the role of 7α,25-OHC/GPR183 on MAPK
activation and neuroinflammation in the DH-SC. Then in Aim 2, we will develop GPR183 antagonists based on
SAE-14 and use a testing funnel to screen to find those with optimal stability and bioavailability for in vivo
pharmacological profiling in rodent neuropathic pain models in Aim 3. Our findings will further our understanding
of GPR183 signaling in neuropathic pain and identify the first small molecule GPR183 antagonists with properties
suitable for non-addictive analgesics development addressing a key mission of the HEAL initiative.

Public health relevance
We have recently identified a role for GPR183 in neuropathic pain states. Here, we will investigate the roles of GPR183 and its ligands in neuropathic pain and develop selective GPR183 antagonists as novel no-opioid based analgesics. Our studies address a huge and pressing unmet medical need.